Miami Clinical and Translational Science Institute

Project Summary
Located in South Florida (SoFL), the goals of University of Miami’s Clinical and Translational Science Institute
(CTSI) are to improve the health of our community, address health disparities, and promote health equity. The
CTSI accomplishes these goals by catalyzing the development, demonstration, and dissemination of
scientific and operational innovations that improve the efficiency, effectiveness, and quality of clinical and
translational research. This is done through bidirectional engagement of diverse stakeholders, including
patient advocates and community collaborators, to help identify gaps, challenges, and chokepoints in the
translational research process. In response, the CTSI develops and test stakeholder-driven resources, tools,
and interventions ultimately promoting the adoption and integration of those that are demonstrated to be
successful, through dissemination and implementation efforts. This work is shaped by three primary factors:
1) SoFL is characterized by complex and multifaceted diversity with respect to race, ethnicity, language,
immigrant status, socioeconomic disadvantage, and stigmatization. This complexity allows CTSI Hub
investigators to explore research questions difficult to conceptualize and evaluate elsewhere; 2) CTSI
prioritizes diversity, equity, inclusion, and accessibility (DEIA) in its scientific workforce and research
participants; and 3) CTSI has a strong, successful and sustained record of authentic community and
stakeholder engagement which facilitates multidisciplinary research that can successfully overcome the
translational pitfall of replicating existing inequities. The CTSI’s focus, scope of activities and aims are
grounded in an understanding of these factors and their complex interplay with one another. Together with
diverse stakeholders, the CTSI will: 1) support the development and dissemination of innovative resources and
services to increase the quality, efficiency, and effectiveness of research across the entire translational
research spectrum; 2) promote research collaborations aimed at facilitating and accelerating research to
improve community health, address health disparities, and promote health equity; 3) develop innovative
training programs to support a team science-oriented CTS workforce, from translational scientists to clinical
research professionals and key stakeholders; and 4) support CTS research responsive to these overarching
goals. Through these efforts, the CTSI expects to achieve significant improvements in the quality, safety,
efficiency, effectiveness, and informativeness of its Clinical and Translational Enterprise. The CTSI will then
broadly disseminate its acquired knowledge regionally and nationally to maximize impact and opportunity, both
now and in the future. By doing so, the CTSI accelerates bringing the benefits of translational science (more
effective treatments, drugs, devices, behavioral interventions, and medical procedures) to all people,
regardless of their identity or access.
PHS 398/2590 (Rev. 06/09) Page Continuation Format Page

Public health relevance
Project Narrative The goals of the University of Miami’s Clinical and Translational Science Institute are to improve the health of our community, address health disparities, and promote health equity. The CTSI will accomplish these goals by developing solutions to improve the efficiency of our research enterprise. In so doing, we will ensure that new discoveries and best practices equitably benefit the health of all patients and communities. PHS 398/2590 (Rev. 06/09) Page Continuation Format Page